Operations Core

The Operations Core (OC) supports OAIC investigations of multifactorial geriatric conditions by recruiting
and retaining diverse populations of older persons, seeking input from the local community in research
planning and dissemination, monitoring participant safety, ensuring regulatory compliance, developing surveys
and instruments, designing Information Technology (IT) systems to implement research, collecting and
preparing data for statistical analysis, and providing continuity and shared knowledge across projects. The
overall goal of the OC (RC1) is to ensure the successful implementation of research focused on multifactorial
geriatric conditions. This goal will be accomplished by leading, managing, and coordinating the effective,
efficient and innovative use of facilities, data, staff, resources, and space. There is a consistent demand for
experienced personnel with the ability to quickly execute aging-focused research and an increasing need for
informatics skills and technology to streamline work.
The Specific Aims of the OC are: 1) to provide an infrastructure suitable to support Yale OAIC-funded
projects and External Projects. This infrastructure includes experienced personnel, staff training modules,
standard operating procedures for conducting field studies, and comprehensive clinical research informatics
(CRI) services; 2) to collaborate with the REC, PESC, and Biostatistics Core (RC2) to develop specific CRI and
field operations systems for Yale OAIC-funded projects and External Projects; and 3) to conduct innovative OC
Development Projects that advance the mission of the Yale OAIC.
During the current funding cycle (2013-present), the Operations Core was integrally involved in research
support of 80 OAIC-funded projects and External Projects, numerous collaborations within Yale, and
engagement with several other Pepper Centers. Altogether, these efforts have resulted in 114 peer-reviewed
publications and 81 extramurally funded grants (>$145 million total costs) of which 25 involved 18 junior faculty
specializing in aging/geriatrics research. During the next funding cycle, the OC will: (1) collaborate on 4 of the
5 proposed REC and PESC projects, 24 of the 29 funded External Projects, and 7 pending projects from grant
submissions involving more than $13 million in total costs; (2) substantially expand and enhance the clinical
research informatics infrastructure at Yale School of Medicine, in partnership with leaders from each clinical
research support center; and (3) lead an innovative Development Project, the Clinical Decision Support
System (CDSS) Toolkit, that will make it possible for any research team having access to REDCap to
implement a sophisticated, HIPAA-secure CDSS. The CDSS toolkit will support the growth of projects related
to the OAIC subtheme of individualized decision making for older persons with multiple chronic conditions.